ANABOLIC EFFECT OF GROWTH HORMONE AND RESISTANCE EXERCISE IN YOUNG/ELDERLY MEN

The effects of heavy resistance exercise and growth hormone administration alone and in conbination on skeletal muscle and whole-body protein metabolism will be studied using stable-isotope labelled tracers and muscle biopsies in young and elderly subjects.